Center for Limb Loss Prevention and Prosthetic Engineering

PROJECT SUMMARY
The mission of our VA Rehabilitation Research and Development Center for Limb Loss Prevention and
Prosthetic Engineering is to improve the quality of life and functional status of veterans who are at risk for, or
have undergone, a lower extremity amputation. The Center brings together investigative teams that identify
clinical problems, model them into hypothesis-driven research, conduct experiments, and make evidence-
based conclusions before disseminating the results to veteran, clinical, and scientific audiences.
Our Center includes three major cores: (1) Limb Loss Prevention, (2) Prosthetic Engineering, and (3)
Rehabilitation Outcomes. The Limb Loss Prevention core aims to reduce functional and anatomical limb loss
by studying the disease processes that lead to aberrant limb function and by developing novel, state-of-the-art
technologies for studying the foot. Highly specialized techniques, such as biplane fluoroscopy, cadaveric gait
simulation, gated MRI loading, and computational modeling, will be employed to quantify the effects of foot
deformity, ankle arthritis and diabetes, and to compare the effect of different treatment options. The Prosthetic
Engineering core aims are to enhance mobility, reduce the risk of injury, and improve the comfort of veteran
amputees. We address these needs by designing and evaluating novel state-of-the-art prostheses that leverage
advances in robotics, computation, and instrumentation. The Rehabilitation Outcomes core integrates the
complex multi-dimensional issues of medical co-morbidity, psychological status, and social factors and their
impact on amputee functional outcome. The development and evaluation of group-based therapeutic
interventions, and the improvement of the amputation level decision making process are the foci of this core.
Since our last Center renewal in 2012, we have been awarded $5.4M in intramural funding via 15 VA RR&D
grants and $3.3M in extramural funding via 6 non-VA federal grants. During the same fiscal period (2013-
2015), the Center has published 69 peer-reviewed articles, 5 book chapters, 3 conference papers, 67 conference
abstracts, and our investigators have given 108 presentations and invited lectures. We have also expanded our
research capabilities through many successful collaborations with multiple departments at the University of
Washington, other top-tier research Universities, leading research institutions, VAPSHCS Health Services, and
ERIC (Epidemiology Research an Informatics Center) investigators, as well as clinician/scientists at other VA
Medical Centers. Our current 6,300 square feet of laboratory and office space will nearly double, and be
transformed into state-of-the-art research facilities when we transition into the new Mental Health and
Research Building in 2017.
Our Center includes a group of highly productive and recognized senior investigators including two who have
won the prestigious Paul B. Magnuson Award for Rehabilitation Research and two recipients of VA Research
Career Scientist awards. We have also recruited three early-career PhD researchers and two Career
Development Award winners who bring important skillsets to further advance the Center mission. Our Center
investigative team includes clinician/scientists with expertise in Orthopaedics, Rehabilitation Medicine, and
Rehabilitation Psychology. This strong clinical linkage ensures that our research is relevant to the veteran
patients who are the focus of our work. We have developed an impressive training program to create a new
generation of scientists who will contribute to veteran care including: undergraduate, graduate and medical
students, post-doctoral fellows, interns/residents, and clinical fellows. Our Center’s work is further enhanced
by a skilled research team including: MS engineers, research assistants, a biostatistician, and a prosthetist. In
summary, this Center has developed a remarkable infrastructure that has enabled it to conduct both high
quality, and highly prolific research that is responsive to the emerging needs of our veterans.

Public health relevance
PROJECT NARRATIVE (RELEVANCE TO VETERANS) Our Center’s primary goal is to restore the function of veterans who have lower limb impairments related to trauma, disease, or deformity. To prevent loss of function, we aim to understand the causes of and expand the treatment of painful conditions of the foot such as arthritis and flatfoot. Additionally, we will reduce the risk of amputation by studying factors that contribute to diabetic foot ulcers. For veterans whose amputation cannot be prevented, we aim to optimize patient/provider amputation level decision-making. Through the generation of novel prosthetic designs, we will augment function by reducing residual limb skin injury, enhance the thermal environment of the socket, and improve amputee mobility over complex terrains and transitions. Finally, realizing that optimum rehabilitation includes psychological and social restoration, we will expand our understanding of these complex interactions and subsequently evaluate and develop new treatment strategies.